Great Lakes Center for Occupational Health and Safety

Overall The Great Lakes Center for Occupational Health and Safety/Illinois Education and Research Center
(GLC-OHS) has been funded by the National Institute for Occupational Safety and Health since 1977. Our
mission is to improve, promote, and maintain the health of workers and communities through innovative and
interdisciplinary activities, with the Specific Aims to 1) Educate graduate students for professional practice
and/or research and to prepare them to contribute to the advancement of occupational and environmental
health, safety, equity, inclusion, and well-being. 2) Prepare OHS professionals to be leaders who expand
awareness of and solutions for improving public and worker health, safety, equity, inclusion, and well-being. 3)
Enhance the capabilities of employers, worker organizations, government agencies and communities to solve
occupational and environmental health, safety and well-being challenges through outreach and technical
assistance. 4) Enrich the knowledge base for solving current and future occupational and environmental health
safety and well-being issues through academic, research and practice-based experiences. 5) Foster networks
of academic, professional and community organizations that advocate for and raise awareness of occupational
and environmental health, safety, and well-being issues. 6) Translate and disseminate OHS best practices in
partnership with diverse local, regional, national partners and community groups. Our facilities span two
campuses of the University of Illinois – the University of Illinois at Chicago (UIC) and the University of Illinois at
Urbana-Champaign (UIUC), and multiple colleges on those two campuses including the School of Public
Health (SPH), the College of Engineering (COE) and the College of Agricultural, Consumer and Environmental
Sciences. The administration of the GLC-OHS is based in the Division of Environmental and Occupational
Health Sciences (EOHS) in the UIC SPH. The current GLC-OHS is comprised of 9 programs. With the addition
of a proposed reconfigured Targeted Research Training program, we are proposing a total of 10 programs:
Agricultural Safety and Health, Industrial Hygiene, Occupational and Environmental Epidemiology,
Occupational Medicine, Occupational Safety, Planning and Evaluation, Targeted Research Training –
proposed, Continuing Education, Outreach, Pilot Projects Research Training. Degrees offered by the GLC-
OHS include Master of Public Health, Master of Science in Public Health, and Doctor of Philosophy. Our
trainees are funded with stipends and tuition support, and in addition to their academic programs they
participate in robust inter-disciplinary activities. With this proposal we have included new focus on diversity,
equity, and inclusion in our recruitment and retention of trainees and faculty, and we have included a new
emphasis on training and research on the application of artificial intelligence to occupational safety and health.

Public health relevance
Narrative Overall The mission of the Great Lakes Center for Occupational Health and Safety is to improve, promote, and maintain the health of workers and communities through innovative and interdisciplinary activities such as training future OSH professionals, fostering networks and partnerships across industries and community and expanding the scope of current research in OSH.